CHD4-MEDIATED TRANSCRIPTIONAL REGULATION OF PANCREATIC BETA CELL DEVELOPMENT AND FUNCTION

PROJECT SUMMARY / ABSTRACT
Diabetes is a global epidemic that is expected to become even more severe. Although there are treatment
options, such as exogenous insulin, one of the most promising long-term treatments is transplanting donor islets
into diabetic patients. While this treatment can allow patients to maintain normal blood glucose levels for
extended periods of time, there is an extreme lack in the amount of viable donor islets for transplantation. To
combat the lack of suitable donor islets, researchers have begun to differentiate human pluripotent stem cells
(hPSCs) into β-like cells that respond to glucose by secreting insulin, with the hopes of creating a limitless supply
of transplantable pancreatic β cells. This approach has been somewhat successful; however, the current
differentiation protocols lack the ability to make pure populations of β cells and often result in immature β cells
and polyhormonal cell populations. More complete knowledge of the transcriptional networks and associated
cofactors required in the differentiation and function of pancreatic β cells is needed to supplement the current
hPSC differentiation protocols and provide the information required for better diabetes treatment options. One
such cofactor is the chromodomain helicase DNA-binding protein 4 (CHD4). CHD4 is the motor protein of the
nucleosome remodeling and deacetylase (NuRD) complex and, along with histone deacetylase 1 and 2 (HDAC1
and 2), CHD4 creates condensed chromatin states, thereby repressing genes. Preliminary data has shown that
CHD4 interacts with essential transcription factors in pancreatic β cells. Furthermore, my preliminary data shows
that the loss of CHD4 in the β cells of mice causes hyperglycemia along with glucose intolerance. This suggests
that CHD4 is a necessary transcriptional cofactor in the function of β cells. A better understanding of the role
CHD4 plays in the development and function of pancreatic β cells could provide additional information to facilitate
the directed differentiation of β cells from hPSCs in vitro. In this proposal, using both in vivo and in vitro
experiments, I will determine the role and mechanism of CHD4 in the development and function of
pancreatic β cells.

Public health relevance
PROJECT NARRATIVE Diabetes is a global health epidemic caused by the destruction and/or dysfunction of pancreatic β cells. This project focuses on elucidating the role of the transcriptional cofactor CHD4 during the development and function of pancreatic β cells. This knowledge will be essential in establishing better differentiation protocols for generating fully functional β cells from human pluripotent stem cells.